Shared Resource - Proteomics & Metabolomics Shared Resource

ABSTRACT
The molecular characterization of disease processes has become an indispensable component of current cancer
research. The mission of the Proteomics & Metabolomics Shared Resource (PMSR) is to provide state-of-the-
art chromatographic and mass spectrometric services for proteomics and metabolomics applications. The PMSR
was established in 2006 for proteomics and expanded to metabolomics in 2008. Since the last review, PMSR’s
activity and throughput have expanded dramatically; the PMSR provided services to 22 Georgetown Lombardi
Comprehensive Cancer Center (LCCC) members in fiscal year (FY) 2017. Radoslav Goldman, PhD, oversaw
proteomics operations through 03/2018, at which time he stepped down to focus on directing his newly formed
Glycoscience Center. Byers replaced Goldman. Byers is the founder and a former director of the PMSR.
Proteomics services include optimizing workflows and developing specialized services, which include identifying
proteins and peptides and their modifications and quantification. Targeted liquid chromatography-mass
spectrometry (LC-MS) experiments for specific proteins and their modifications facilitate the conduct of
translational research applications. Cheema manages the metabolomics component. The metabolomics
component includes comprehensive metabolomics and lipidomics profiling services from a variety of matrices,
including tissue and cultured cells and biofluids, such as serum, plasma and urine. The PMSR has developed
and optimized methods for protein and metabolite extraction from complex matrices such as cells, feces, ductal
lavage fluid and cerebrospinal fluid. The proteomics and metabolomics services also include multiple reaction
monitoring (MRM)-based targeted quantification, and metabolomics services further include high-resolution MS
for small molecules. The Waters Corporation recognized the metabolomics component as a Center of Innovation.
Waters has continually supported high-impact science, resulting in multiple extramurally funded grants with a
metabolomics focus in at least one specific aim.